ISOTHIOCYANATES AND NITROSAMINE CARCINOGENESIS

Program 1: Isothiocyanates: Structure-Activity Relationships Program 2: Isothiocyanates an Inhibitors of Esophageal Cancer Program 3: Mechanisms of Inhibition of Nitrosamine Bioactivation by Isothiocyanates Program 4: Chemoprevention of Nitrosamine Carcinogenesis